BCCMA: Overcoming chemoresistance in ovarian cancer: Identification and validation of biomarkers and targetable drivers of platinum resistance

This Collaborative Merit Award application (CMA), consisting of three projects (CMA1-3), addresses a critical
challenge in the clinical management of ovarian cancer (OC). The most common and lethal subtype of OC is
high-grade serous ovarian carcinoma (HGSOC). Standard treatment for HGSOC combines surgical
cytoreduction with platinum-based chemotherapy. Patients diagnosed with HGSOC often suffer from disease
relapse associated with the emergence of chemotherapy resistance. The clinically necessary key to increasing
survival in HGSOC is to prevent the development of platinum resistance (PtR) or identify alternative means of
targeting PtR tumors. The main goal of this interdisciplinary and collaborative project is to identify novel targets
and biomarkers of therapeutic efficacy for HGSOC. This requires a better understanding of the mechanisms that
result in transformation of HGSOC cells to an aggressive, therapy-resistant phenotype. Increasing evidence
supports the hypothesis that a key contributor to PtR is the reprogramming of cancer cells into a less
differentiated and metabolically adaptable state. This collaborative proposal by three established OC researchers
will leverage their interdisciplinary expertise and rich resources to define new mechanisms of resistance in
OC. CMA1 will use digital spatial profiling and systems biology to provide a holistic understanding of PtR as well
as prioritize cell-intrinsic and microenvironmental clinically relevant underlying molecular pathways. Unique
preclinical immunocompetent mouse models and co-culture models will be used to study the role of the tumor
microenvironment in PtR. CMA2 will study metabolic adaptation associated with the emergence of PtR focusing
on a shift to fatty acid oxidation in PtR HGSOC tumors. CMA2 will use resources shared with CMA1&3 and
cellular biology and novel single cell metabolic imaging to define unique metabolic dependencies of PtR HGSOC.
As PtR tumors are highly susceptible to death induced by oxidized lipid membranes, mechanisms of ferroptosis
will be examined in PtR models treated with novel metabolism targeting agents, which will be tested
with CMA1. CMA3 will explore the reprogramming of recurrent HGSOC cells into more dedifferentiated tumor
subpopulations with neuroendocrine (NE)-like features. Mounting evidence in other tumors suggest progression
to a NE-like state results in therapy resistance - a concept yet to be explored in OC. To identify NE-like cells in
OC, the transcriptome, proteome, gene vulnerability, and drug sensitivity landscape of matched patient tumors
and model systems will be evaluated for the emergence of NE-like cells under chemotherapeutic pressures.
Existing drug dependency databases will be mined for identification of druggable targets in NE-like cells. Drugs
effective against these cells will be tested alone or in combination as targeted therapy for PtR OCs utilizing
patient derived organoid and xenograft models. Hallmarks of NE-like cells including metabolic adaptations and
histologic characteristics will be explored with CMA2 & CMA1 respectively.
CMA1 rationale: The evaluation of histopathology slides is the main method to establish a HGSOC diagnosis
and guide treatment decisions. However, the rich data embedded within histopathology slides have not been
fully exploited to understand the underlying causes of PtR and develop personalized treatment strategies. Prior
research on PtR mostly used cancer cell lines and focused on cell-intrinsic events. However, data from clinical
samples suggest that the tissue microenvironment (TME) is a major driver of PtR. Specifically, cancer-
associated fibroblasts (CAFs) were shown to induce PtR in adjacent cancer cells. We hypothesize that higher-
order features extracted from pathology slide images are associated with distinct molecular profiles, such as
specific gene and protein expression, metabolism, and sensitivity to specific drugs. We will combine spatial
image profiling with assays in mouse models and CAF/cancer cell co-cultures to mechanistically dissect the
role of the TME in PtR. The integration of image data from patient slides with other -omics data will add a key
layer of information to prioritize biologically- and clinically-relevant biomarkers and drivers of PtR.

Public health relevance
This Collaborative Merit Award application (CMA) is a synergistic, multidisciplinary project focused on the mechanistic understanding of platinum resistance (PtR) as the foremost cause of death in ovarian cancer patients. The overall strategy is to integrate ideas, resources, and expertise in advanced technologies to identify and validate novel therapeutic targets and biomarker-driven treatments for ovarian cancer patients. This application (CMA1) will identify biomarkers and underlying molecular pathways of platinum resistance as well as test potential targeted therapies that prevent or overcome PtR. CMA1 is highly integrated with the other two applications and will serve as a resource for CMA2 and CMA3 to identify and validate biomarkers and molecular mechanisms of platinum resistance. The major contribution of CMA1 is to generate a comprehensive integrated mechanistic multi-omic database that will facilitate the development of biomarker-driven mechanism-based cancer therapies for extending survival and improving the quality of life of Veteran women.